DETECTION OF OCCULT HBV INFECTION IN LIVER TRANSPLANTS UNDERGOING HBIG THERAPY

The goals of study are: i)evaluate pharmacokinetics of HBIg in liver transplants receiving this therapy as long-term prophylaxis for recurrence of HBV surface antigenemia; ii)examine concurrent changes in titer of HBsAg and anti-HBs during HBIg therapy; iii)determine whether pts on HBIg who are HBsAg negative have residual HBV infection in serum liver or lymphocytes; iv)determine whether immune complexes can be identified and quantitated; v)determine whether HBV escape mutants are responsible for overt reinfection.